Unveiling the gut's sensory code: Implications for food, development, and disease

PROJECT SUMMARY
This research aims to revolutionize the understanding of nutrition by investigating the concept of
"nutritional memory," which posits that early-life dietary experiences create lasting impressions on gut
neuropod cells that influence lifelong food choices and consumption patterns. This paradigm shift
challenges the traditional calorie-centric view and proposes that the gut acts as a sensory organ,
communicating vital nutrient information to the brain.
The research will be conducted in three parts: 1) Characterization of the sensory landscape of gut neuropod
cells, utilizing calcium imaging and electrophysiology to identify and profile nutrient receptors; 2)
Elucidation of the role of long-lived neuropod cells in shaping food preferences, analyzing how early-life
dietary exposure influences their transcriptome, epigenome, and proteome; and 3) Establishment of
causality and exploration of therapeutic potential by ablating long-lived neuropod cells and assessing the
impact on food preferences and metabolic health.
The potential outcomes of this research are transformative, including: 1) identification of the molecular
mechanisms underlying nutritional memory, 2) development of innovative interventions to reprogram
unhealthy food preferences and combat diet-related diseases, and 3) establishment of new dietary
guidelines for pregnant women and infants to reduce health disparities. The investigator is uniquely
positioned to undertake this ambitious project, with a strong technical and conceptual foundation, a team of
world-renowned experts, and a collaborative approach to unravel the mysteries of gut sensory memory and
create a healthier future for generations to come.

Public health relevance
PROJECT NARRATIVE This research seeks to understand the impact of early-life dietary experiences on lifelong food preferences by exploring the novel concept of "nutritional memory." By unraveling the mechanisms behind this phenomenon, this research could lead to innovative strategies for addressing diet-related diseases such as obesity, diabetes, and cardiovascular disease. Ultimately, this research aims to improve public health by establishing new dietary guidelines and interventions, particularly for pregnant women and infants, to reduce health disparities and promote healthier eating patterns throughout life.